Streptococcus mutans diadenylate cyclase: A promising target for preventing dental caries

Project Summary
The tenacious biofilms formed by Streptococcus mutans are resistant to conventional antibiotics and current
treatments such as ‘oral rinses’. Current treatments are not ‘biofilm-specific’ and kill pathogenic species as well
as commensal species alike. Therefore, there is a growing need for novel therapeutics to selectively inhibit S.
mutans biofilms while conserving the oral microenvironment. Recent studies from our lab and others’ have shown
that increased levels of cyclic di-AMP (c-di-AMP), an important secondary messenger in S. mutans, favored
biofilm formation by upregulating the expression of gtfB, the gene coding for glucosyl transferase B (GtfB). GtfB
is responsible for the production of water-insoluble glucans and is critical for biofilm formation and virulence of
S. mutans. C-di-AMP is a novel cyclic dinucleotide synthesized from two ATP molecules by the enzyme,
diadenylate cyclase (DAC). A suggested mechanism by which c-di-AMP controls the biofilm formation involves
a c-di-AMP-binding protein (CabPA)’s interaction with VicR, a transcriptional factor known for regulating gtfB. S.
mutans DAC (smDAC) is not an essential enzyme. Therefore, the inhibition of smDAC is a novel strategy to
inhibit the S. mutans biofilms without affecting its growth. DAC inhibition should downregulate gtfB expression
and reduce the glucan production. S. mutans coexists with other oral microbes and its ability to form biofilms
may be influenced by other bacteria. Multi-species biofilms enable the testing of the selectivity of PB8 towards
S. mutans along with other commensal streptococci. We have taken a structure-based approach for the design
of inhibitors using our recently solved crystal structure of smDAC enzyme. With the help of in-silico screening
and preliminary SAR studies, we have identified low micromolar inhibitors of smDAC. The most active compound
identified from these studies is a novel small molecule PB8, which inhibits smDAC (IC50 = 17.2 M) and S.
mutans biofilm (IC50 = 10.2 M). PB8 inhibited 80 % multi-species biofilm at 50 M. PB8 did not affect the growth
of S. mutans and commensal bacteria (S. gordonii, S. sanguinis, and S. parasanguinis) up to 100 µM showing it
is a selective biofilm inhibitor. In surface plasmon resonance (SPR) studies, PB8 showed high binding affinity to
smDAC (KD = 7.1 M). To facilitate the structure activity relationship (SAR) and lead optimization studies, we
have developed a three-step high yielding synthesis of PB8 and conducted preliminary SAR studies. The overall
goal of this proposal is to optimize the biofilm inhibitory activity of PB8 and establish its binding affinity to smDAC
and its potential as novel selective biofilm inhibitor that can be used for the prevention and treatment of dental
caries. The specific aims are: 1) To optimize the biofilm inhibitory activity of PB8 through structure activity
relationship studies. Successful completion of the proposed studies will validate smDAC as a novel target for
biofilm inhibition and identify novel, non-toxic compounds that can selectively inhibit cariogenic biofilms, while
leaving the commensal and beneficial microbes intact. 2) To evaluate smDAC inhibition and biofilm inhibition
profiles of PB8 and its synthesized analogs.

Public health relevance
Project Narrative Treating dental caries infections is a massive healthcare expense due to the high number of cases to remove oral plaque, and mature biofilms are resilient to clinically available antibiotics due to their intricate architecture and strong binding to the hydroxyapatite coating of the enamel. Reported natural antibiofilm agents, such as isolates from Morus alba leaves and plant lectins, have shown moderate antibiofilm activity for S. mutans by targeting glucosyltransferases, yet natural product isolation can be time-consuming and expensive. Since there are no effective antibiofilm therapies provided in clinic, there is a demand for the development of antibiofilm agents that target a signaling pathway of S. mutans and other pathogenic bacteria while keeping the oral microbiome intact.